INFORMATION TECHNOLOGY AND BIOSTATISTICS CORE

The long-term objective of the ITBC is to provide advanced information technology and skilled expertise in metric modeling and biostatistics to support the SSCOR in COPD at the University of Pittsburgh. This Information Technology (IT) system will allow basic and clinical research findings to be organized in a quality-controlled, data mart to permit analyses, pharmacometric modeling, and statistical analyses to support all of the projects included within this proposal. The research proposal will accomplish the following specific aims in order to achieve stated objectives. Specific Aim 1: To provide comprehensive IT support to all investigators, all projects (especially project 1, 2, and 3), and all cores in this proposal. Specific Aim 2: To provide statistical and mathematical modeling capabilities to all projects (especially intensive for project 1 and project 3) in this proposal. Specific Aim 3: To develop novel methods for data mining and online-analytical processing for all projects in this proposal. The proposed ITBC is being built from an existing core resource from within the Center for Clinical Pharmacology, University of Pittsburgh. The current resource at the Center for Clinical Pharmacology has extensive experience and is capable of supporting a number of NIH-funded projects. The Center's capabilities permit a well-established, fully functional, essential clinical research infrastructure support system to be immediately available to the SSCOR in COPD at the University of Pittsburgh.